Innate DC Govern TH Polarization through the Novel Regulator AIMp1

Abstract
The inability to generate effective cell-mediated immunity outside the context of live virus vaccination continues
to be a pervasive clinical problem for vaccination of immunocompromised individuals, cell-mediated prophylaxis
of viral diseases for which no live vaccines exist, and critically, the generation of durable antitumor immune
responses. Cell mediated immunity is initiated by dendritic cells (DC), a critical lineage of innate immunity that
serves as the principal point of contact and crosstalk between the innate and adaptive arms of the immune
system. Successful response to pathogen requires that DC detect and integrate a broad array of environmental
cues to exact control over critical downstream responses, particularly T-helper (TH) cell polarization. Many such
cues, as well as mechanisms of detection and integration, remain to be understood. In this proposal we will
interrogate the emerging but well-supported hypothesis that DC expression of the novel regulator AIMp1 drives
physiologic propagation of TH1 cellular immunity. This hypothesis is based upon extensive and rigorous data
demonstrating that genetic ablation of AIMp1 produces deficits in TH1 polarization significantly more profound
than those characterized in IL-12 or IL-12R-deficient mice. AIMp1 knockout mice lose the ability to mount an
adaptive immune response against influenza, exhibiting complete lethality to a normally sublethal challenge,
deficient HA-specific IgG2a production, and loss of nearly all IFN-g-secreting T-cells in the lung by post-infection
day 15. AIMp1-/- animals also exhibited complete loss of antitumor immunity that could be rescued by adoptive
transfer of wildtype DC. Mechanistically, the data suggest these deficits are due to defective p38MAPK activation
in AIMp1-/- DC with downstream dysregulation of AP-1 heterodimerization. Direct relevance of AIMp1 to human
disease was validated through a pan-cancer TCGA bioinformatics analysis of 9,000 primary human tumor sam-
ples, revealing an unexpected 70% survival advantage among patients expressing elevated levels of AIMp1 in
the primary tumor. In this dataset, elevated AIMp1 expression was highly correlated with an activated DC gene
signature and TH1 immune profile. Strikingly, this survival advantage was not recapitulated among patients in
which the primary tumor exhibited high levels of IL-12A (p35) expression. These data suggest an unrecognized
yet indispensable role for DC-expressed AIMp1 in adaptive TH1 governance and provide a cogent rationale for
this study: confirmation that a novel regulatory factor is essential for integration and transduction of TH1-inducing
signals in DC will alter the paradigm by which TH1 immune signaling is presently understood. The mechanisms
through which AIMp1 governs cellular immunity will be determined by the completion of three specific aims. In
aim I we will define the in vivo DC subset(s) for which AIMp1 function is critical to propagation of TH1 immunity.
In aim II we will define the manner by which AIMp1 interfaces with the DC regulatory signaling cascade. In aim
III we will define deficits in effector cell function that result from conditional loss of AIMp1 in DC populations. In
all aims, differences between AIMp1-deficiency and IL-12 deficiency will be characterized where appropriate.

Public health relevance
Project Narrative A properly functioning cellular immune response is essential to the eradication of infectious diseases and cancer, whereas inappropriate cellular immune regulation results in debilitating autoimmune conditions. Given that cellular immunity plays such a critical role in the disease process, a better understanding of the innate regulatory mechanisms governing cellular immunity would allow for the formulation of novel vaccine and pharmaceutical interventions that would enormously benefit human health and well-being. Completion of the work outlined herein will permit the immunoregulatory role of a critical basic factor, the novel gene product AIMp1, to become fully elucidated thereby enabling a) simpler production of more effective and less-expensive vaccines and b) the characterization of new druggable target interactions that will form the basis of the next generation of pharmaceuticals for the treatment of cancer, infectious disease, and autoimmune conditions.